Mechanism of Calcium Channel Cava2d1 Protein Mediated Neuropathic Pain

DESCRIPTION (provided by applicant): Nerve injury-induced pain, or neuropathic pain, is a common disorder lacking specific therapeutic agents due to the fact that underlying mechanisms are poorly understood. Peripheral nerve injury induces voltage-gated calcium channel a2d-1 subunit (Cava2d1) expression in dorsal root ganglia and spinal cord that correlates with neuropathic pain development and maintenance, and blocking such an increase results in neuropathic pain reversal. These suggest that Cava2d1 plays a critical role in spinal sensitization that underlies neuropathic pain. To further explore the mechanism underlying spinal sensitization and neuropathic pain mediated by injury-induced Cava2d1 upregulation, we plan to test the hypotheses that (1) injury-induced upregulation of the Cava2d1 interacts with injury-induced synapse inducer, thrombospondin-4 (TSP4) in dorsal root ganglia and spinal cord; (2) Both injury-induced Cava2d1 and TSP4 contribute to initiation and maintenance of neuropathic pain by (3) promoting spinal synaptogenesis. First, we will examine the spatial and temporal interactions between Cava2d1 and TSP4 in dorsal spinal cord and DRG in relation to neuropathic nociception using Western blots and immunohistochemical techniques. Second, we will compare the contribution of TSP4 to behavioral hypersensitivity observed in transgenic mice overexpressing the Cava2d1 or spinal nerve injured rats with elevated Cava2d1 expression. Finally, we will determine if co-upregulation of Cava2d1and TSP4 by nerve injury leads to enhanced synaptogenesis in the spinal dorsal horn that contributes to neuropathic pain. Completion of these studies will allow us to extend our current knowledge about the mechanisms of injury-induced Cava2d1 upregulation and its contribution to the induction and maintenance of neuropathic pain.

Public health relevance
Chronic pain derived from nerve injury, or neuropathic pain, is a common clinical syndrome lacking specific and effective therapeutic agents due to the fact that its cellular mechanisms are poorly understood. Existing data indicate that injury-induced voltage-gated calcium channel α2δ-1 subunit (Cavα2δ1) in dorsal root ganglia and spinal cord contributes to the development of neuropathic pain. However, mechanisms underlying injury-induced Cavα2δ1 in neuropathic pain are not known. We hypothesize that elevated Cavα2δ1 interacts with thrombospondin-4 (TSP4) post injury in promoting synapse formation, and abnormal synapse formation plays a causal role in neuropathic pain. We will test this hypothesis using genetically modified mice, nerve injury models, biochemical, electrophysiological, and behavioral pharmacology approaches. Completion of this study will provide important information for the understanding of neuropathic pain mechanisms and the development of next generation of neuropathic pain medications.